Exercise Option Period 1 and fund 127 additional cases in the amount of $59,245.50 (127 cases X $3,110 per case X 15%).

The contractor collected biospecimens included tumor tissue, normal tissue, and blood according to an NCI-provided protocol. The biospecimens were used for proteogenomic characterization studies. The contractor collected corresponding clinical data including medical history, demographic information, diagnostic data, and annual follow-up reports.